Core C - Genomics, Animal Models and Advanced Phenotyping Core

CORE C – GENOMICS, ANIMAL MODELS AND ADVANCED PHENOTYPING
PROJECT SUMMARY/ABSTRACT
The goal of the Cardiorenal and Metabolic Disease Research Center (CMDRC) COBRE is to bring together
a multidisciplinary group of basic, clinical, and population scientists to work synergistically on the theme of
cardiorenal and metabolic diseases. During Phase 1, CMDRC-Core C provided COBRE investigators and
external researchers' access to technical expertise and equipment to perform a wide variety of molecular,
genetic, microarray and gene expression studies that would otherwise not be possible. Core C also provided
investigators at UMMC access to novel transgenic and knockout mouse and rat models of cardiovascular
renal and metabolic disease that are only available at UMMC. In total, CMDRC-Core C completed several
hundred genomic studies as well as generated thousands of animals for detailed phenotyping resulting in
numerous publications and several NIH R01 funded grants. In Phase II, CMDRC-Core C major project, pilot
grants, and external researchers will have access to state-of-the-art genomic technologies through the
Genomics Sub-Core and large collection of animal models (inbred, transgenic, and gene-edited rat and
mouse models) as well as advanced phenotyping methodologies through the Animal Models and Advanced
Phenotyping Sub-Core. Core C has four aims: (1) to provide CMDRC investigators access to technical
expertise and cutting-edge genomic services, including next generation sequencing technologies (RNA
sequencing, 16S microbial sequencing, custom amplicon panels, whole genome sequencing, and exome
sequencing); (2) to provide CMDRC investigators access to large collection of unique animal models of
obesity, cardiorenal and metabolic diseases, along with training in advanced phenotyping techniques; (3) to
provide education and training opportunities for students, trainees, and faculty in genomics technologies and
advanced animal phenotyping; and (4) to provide continuous improvement in existing assays, services, and
enhance technological capabilities through acquisition of new cutting-edge instrumentation that will assist in
sustainability of the Core. Therefore, it is the objective of the CMDRC-Core C to aid investigators in advancing
scientific discovery in obesity, cardiorenal, and metabolic diseases through application of state-of-the-art
genomic technologies, specialized animal models, and advanced physiological measurements to generate
greater insight into these diseases. Aside from CMDRC investigators, continued funding of the COBRE during
Phase II will have a significant impact on providing external researchers (at other Mississippi undergraduate
institutions and Historically Black Colleges and Universities (HBCUs)] access to equipment and expertise that
would otherwise not be available in our region of the country.

Public health relevance
CORE C – GENOMICS, ANIMAL MODELS AND ADVANCED PHENOTYPING PROJECT NARRATIVE Obesity, cardiorenal and metabolic diseases are significant health problems in the United States, especially in Mississippi. Therefore, it is the goal of the Cardiorenal and Metabolic Diseases Research Center (CMDRC)- Core C to provide researchers access to state-of-the-art genomic technologies, specialized animal models, and advanced physiological measurements to generate greater insights into these diseases.